mHealth-CArdiac REhabilitation for INOCA (INOCA-CARE)

(parent award)
PROJECT SUMMARY. Patients with ischemia with no obstructive coronary artery disease (INOCA) experience debilitating symptoms that include angina, dyspnea, and fatigue. Management of INOCA is challenging, both because there is no option for coronary revascularization to improve symptoms and because available medications are often insufficient. Millions of patients are affected by INOCA in the US. While cardiac rehabilitation (CR) has strong potential to improve outcomes in patients with INOCA, patients with angina are rarely referred (~7% overall, likely lower for INOCA). Even when they are referred, patients face multiple obstacles to participation that include long distances to facilities, high out-of-pocket costs, transportation issues, and competing needs such as work and caregiving responsibilities. Given the limitations of traditional CR, there has been a recent proliferation of mobile health-enabled CR platforms (mHealth-CR) that use portable electronic devices to deliver CR at home. mHealth-CR seeks to replicate components of traditional CR (e.g., exercise counseling) while adding remote monitoring technology to quantify physical activity and other metrics. While mHealth-CR programs are now widely available, to our knowledge they have not yet been tested in patients with INOCA. Given that INOCA is characterized by worse quality of life than obstructive CAD and poor correlation between symptoms and ischemia, the efficacy of mHealth-CR needs to be evaluated before being prescribed in routine practice. In this context, we designed INOCA-CARE (mHealth-CArdiac REhabilitation for INOCA), a phase II pragmatic randomized trial of 250 participants at 2 sites with clinical expertise in INOCA (NYU Langone Health and Emory Healthcare). INOCA will be defined as symptoms of ischemia, positive stress test and/or invasive coronary function test for ischemia and no obstructive coronary disease on imaging. Participants will be randomized 2:1 to mHealth-CR, delivered over 3 months, or usual care, and will be followed for 12 months. In Aim 1, we will test whether an mHealth-CR intervention improves outcomes at 3 months, including angina-related health status (primary endpoint). In Aim 2, we will evaluate effects of the intervention vs. usual care on physical activity and exercise capacity, general health status, and depressive symptoms (secondary endpoints). We will also evaluate effects at 6 months and 1 year. In Aim 3, we will characterize engagement with mHealth-CR and elucidate any factors that limit engagement. Subgroup analyses will be performed for all aims. The MPIs are physician scientists with complementary expertise in INOCA (Reynolds) and mHealth interventions (Dodson). Our findings have the potential to establish mHealth-CR as a novel treatment option to improve outcomes in people with INOCA.

Public health relevance
(parent award) Patients with a condition called ischemia with no obstructive coronary artery disease (INOCA) have symptoms including chest pain, fatigue, and depression, and there are currently few effective treatment options. Cardiac rehabilitation, which is an organized way to deliver exercise and lifestyle counseling, has the potential to work for these patients but there are many factors that can make participation difficult (for example, if there are no facilities nearby). Our study will test whether a new platform for cardiac rehabilitation, delivered by an electronic tablet device paired with weekly remote counseling (known as mobile health cardiac rehabilitation), will improve how INOCA patients feel after 3, 6, and 12 months.